Multimodal imaging measures to assess synaptic dysfunction in Alzheimer's disease

Alzheimer’s disease (AD) is the most common age-related neurodegenerative disorder, a relentless and fatal
condition of progressive cognitive deficits. The urgency to find a cure for AD has never been stronger. Synaptic
dysfunction and synapse loss are core deficits in AD pathophysiology. A better understanding of synaptic
dysfunction in AD is imperative to develop effective therapeutic interventions. In this R21, we propose a
multimodal imaging study combining structural and functional synaptic measures simultaneously to characterize
synaptic failure in patients with AD. The multimodal composition of our study includes magnetoencephalography
(MEG) to probe synapse physiology and positron emission tomography (PET) to probe synapse density,
together with in-vivo quantification of amyloid (Aβ) and tau depositions. This proposal represents one of the very
first to combine two sophisticated technologies to study synaptic failure in AD. On one hand, MEG provides
quantitative spectral signatures of neural oscillations which represents the most direct, non-invasive, measures
of neuronal and synaptic function in the human brain. Combining the fine spatiotemporal resolution of MEG
spectral analyses with mathematical application of neural mass model (NMM) is a powerful technique to examine
neuronal level details from non-invasive neuroimaging in human subjects. On the other hand, radioligands that
bind to the synaptic vesicle glycoprotein 2A (SV2A) has recently become available to measure in-vivo synaptic
density in the human brain. Here we propose to use a new second generation SV2A ligand, 18F-SynVesT-1, for
the first time in AD research. Defining the relationships between synaptic density and synapse physiology and
their specific relationships to Aβ and tau will broaden the current conceptualizations of AD pathophysiology and
provide novel synaptic biomarkers for early interventional clinical trials. We will conduct a cross sectional pilot
study of 45 participants: 25 Aβ-positive mild cognitive impairment (MCI) and mild-AD-dementia (CDR<1), and
20 age-matched cognitively unimpaired individuals (10 Aβ-negative and 10 Aβ-positive). All participants will
undergo resting state MEG, structural MRI, 3-tracer PET imaging for SV2A (18F-18F-SynVesT-1), Aβ
(florbetaben), and tau (flortaucipir), and complete cognitive and neuropsychological assessments. Our central
hypothesis is that excitatory and inhibitory neuronal deficits will be correlated with reduced synaptic density (18F-
SynVesT-1), and with Aβ and tau depositions (florbetaben and flortaucipir, respectively) in early clinical stage of
AD. We will address two key aims. In Aim 1, we will determine the relationship between impaired synapse
physiology (MEG and NMM) and synapse density (18F-SynVesT-1 retention) in AD. In Aim 2, we will Examine
the associations between binding deficits of 18F-SynVesT-1 PET and AD pathophysiology and cognitive
impairments in early clinical stage AD patients. This project will generate crucial data to define synaptic failure
in patients with AD and preliminary data to design future studies linking clinical investigations in AD patients to
mechanistic findings from basic science.

Public health relevance
PROJECT NARRATIVE Two most important factors that will help development of a successful therapy for Alzheimer’s disease (AD) include: (1) understanding the pathological processes of the disease; and (2) new biomarkers to detect and quantify the pathological processes in patients with AD. This study is designed to deeply characterize the synaptic abnormalities in patients with AD and quantify synaptic deficits using novel, sophisticated, electrophysiological assays and molecular imaging techniques. The findings will generate critical insights about altered neuronal properties in the synapses and their regional distributions associated with amyloid and tau in the human brain.